UTS-1401: A Novel Mitigator of Radiation Injury

Abstract:
Our long term objective is to develop a new class of radiation mitigating agents with attractive chemical, physical
and biological characteristics required to be an effective drug that can be distributed widely. We have identified
a small molecule, UTS-1401 [5-(methylthiomethyl) isoxazole-3-carboxylic acid] which demonstrates mitigation
of hematopoietic stem cell death when administered at either 24h or 48h following whole body irradiation (WBI).
Using the endogenous spleen colony assay we demonstrated a significant mitigating effect (ratio of colony
number with and without UTS-1401) when drug was given 24h or 48h after radiation. We have also recently
demonstrated a significant radioprotection for both mouse survival and hematopoietic stem cells for this
compound for up to 72h before irradiation (Valeriote et al, Radiation Research, 202:16-25, 2024). In this
application, we propose to examine solely the mitigating effect to both the hematopoietic acute radiation
syndrome (H-ARS) in specific aim 1 and the gastrointestinal acute radiation syndrome (GI-ARS) in specific
aim 2 following WBI (with 5% bone marrow protection for specific aim 2). Swiss mice will receive a series of
graded doses of WBI around the LD50 for both syndromes with and without the administration of 150 mg/kg UTS-
1401. The single dose of UTS-1401 being used in all studies is the highest dose administrable due to its aqueous
solubility (in tartrate buffered saline). The radiation mitigation factors will be calculated as the ratio of the LD50
for radiation plus UTS-1401 versus radiation alone. The degree of mitigation will be examined at 24, 48 and 72
h following WBI to determine the timeframe of mitigation after radiation exposure. Three routes of drug delivery,
intravenous (iv), oral, and subcutaneous (sc), will be examined and compared. For all specific aims, both male
and female mice will be separately studied. Radiation will be delivered by electrons from a Linac. In specific
aim 3, we will examine the pharmacokinetics (PK) for 150 mg/kg UTS-1401 comparing the iv, oral, and sc routes
to obtain a determination of both the drug kinetics and bioavailability. The AUC values will be correlated with the
extent of mitigation. Finally, in specific aim 4, we will address the mechanism of action with studies focused on
the role of specific cytokines induced by radiation in the so-called “cytokine storm”. We will assess the time
course changes of TNF-α, IL-1β, IL-6, CSF and TGF-β in blood as well as bone marrow and intestinal mucosa
over 20 days following: UTS-1401 alone, 10 Gy irradiation, and the combination of UTS-1401 and radiation at a
24h interval. The results from these studies are expected to demonstrate an effective first-in-class compound,
UTS-1401, which has a small molecular weight, is chemically stable, nontoxic, aqueous soluble and inexpensive
with radiation mitigating properties which extend for a number of days following irradiation. The mechanism
studies are expected to demonstrate UTS-1401 as a new class of agents for mitigating the cytokine storm
consequent to the irradiation.

Public health relevance
Narrative The objective of this research is to demonstrate that a new compound, UTS-1401, has superior chemical and biological properties to current medical countermeasures to limit the lethal damage suffered by exposed individuals following a nuclear disaster including war, terrorism, reactor malfunction or inadvertent exposure to ionizing radiation. The ability of UTS-1401 to increase the survival of both male and female mice exposed to high dose, whole body irradiation at intervals longer than current radiation mitigating agents (radiation countermeasures) following exposure will be studied and correlated with UTS-1401 levels in the blood and tissue of the irradiated animals. Further, we will demonstrate UTS-1401 to be a first-in-class mitigating agent whose mechanism involves pro-inflammatory cytokine modulation setting it apart from current agents and providing a cost-effective, stable and versatile addition to the USA defense against radiation incidents.